Role of JAK2-PAK1 interaction in prolactin-dependent signaling

DESCRIPTION (provided by applicant): In normal mammary development, the hormone prolactin (PRL) is critical for alveolar proliferation and differentiation. Increasing evidence supports the involvement of PRL in breast cancer, the leading type of cancer in women and the second leading cause (after lung cancer) of cancer death among women. In 2008, 40,480 women are expected to die from breast cancer in the U.S. The prolactin receptor (PRLR) is detected in 80% of human breast cancers and is overexpressed in breast cancer cells. Normal and tumor mammary epithelial cells synthesize PRL and PRLR, thus the PRL could behave as an autocrine growth factor for human breast cancer cells. These results suggest the need for a more complete understanding of PRLR signaling in breast cancer. Tyrosine (Tyr) kinase JAK2 was identified as a PRLR-bound signaling molecule. Identification of the proteins recruited to the PRLR-JAK2 and dissection of the signaling pathways that are subsequently activated will ultimately provide a basis for understanding PRL action. Preliminary data demonstrate that the serine-threonine kinase PAK1 associates with and is Tyr phosphorylated by JAK2. Two-dimensional peptide mapping identified three Tyr(s) of PAK1 which are phosphorylated by JAK2. Tyr phosphorylation of PAK1 by JAK2 was also shown to increase cell motility. In this grant we propose to examine the hypothesis prolactin-dependent JAK2 phosphorylation of PAK1 regulates PAK1 activity. Activated PAK1 regulation of target proteins may depend on phosphorylation events or/and protein-protein interactions, leading to the formation of a multiprotein complex that modulates the actin cytoskeleton, increases cell motility and invasiveness, mediates cyclin D1 gene transcription and affects tumorigenicity of human breast cancer cells. Aim1 will determine the role of JAK2-phosphorylated PAK1 in regulating PRL-dependent actin cytoskeleton rearrangement, cell motility and invasiveness. Aim2 will determine the role of PAK1 in regulating PRL-activated cyclin D1 gene transcription. Finally, Aim3 will determine whether JAK2 phosphorylation of PAK1 affects the tumorigenicity of human breast cancer cells in vivo. Because both PAK1 and PRL have been implicated in breast cancer, the proposed studies may ultimately fill out the existing gap between upstream PRL-PRLR-JAK2 events and downstream PAK1-dependent functions in our understanding of the mechanism of human breast cancer. Tyr phosphorylation of PAK1 by JAK2 is likely to represent a novel molecular target in the search for the etiology and treatment of human breast cancer.

Public health relevance
PUBLIC HEALTH RELEVANCE: Prolactin (PRL) was discovered in 1928 as a pituitary factor able to stimulate mammary gland development and lactation in rabbits, as well as the production of crop milk in pigeons. A few years later, the name prolactin was given, based on its ability to stimulate milk production. More than 300 separate biological activities have been attributed to PRL. These biological functions are mediated by specific membrane receptors. These receptors are non tyrosine kinases, they transduce the signal via associated kinases that are recruited by the receptor and activated upon ligand binding. One of these kinases is JAK2 tyrosine kinase. We have recently shown that another protein - PAK1 - is a novel substrate of JAK2. We showed that JAK2 binds to PAK1 and makes PAK1 more active. Activated PAK1 contributes to better cell survival and cell migration. However, how these two proteins work together and the precise mechanism of their action is unknown. PRL is also involved in breast cancer. Breast cancer is the most commonly diagnosed cancer in women - nearly 1 in 3 (30%) of all cancers in women occur in the breast. Based on the current life expectancy for women in the United States, 1 out of 9 women will develop breast cancer in her lifetime - a risk that was 1 out of 14 in 1960. Much is still unknown regarding the molecular biological mechanism by which a normal cell becomes a cancer cell. Our long term goal is to understand the molecular mechanisms of PRL action and disregulation of which leads to human diseases including breast cancer. Toward this aim, we have started to analyze the relationship between JAK2 and PAK1. In the current proposal we will study how JAK2 and PAK1 increase cell migration and cell survival, and which genes are regulated by these two proteins. Understanding how these proteins work together will help to design new therapeutic approaches and possibly drugs for treatment of different human diseases and breast cancer. Project Narrative Prolactin (PRL) was discovered in 1928 as a pituitary factor able to stimulate mammary gland development and lactation in rabbits, as well as the production of crop milk in pigeons. A few years later, the name prolactin was given, based on its ability to stimulate milk production. More than 300 separate biological activities have been attributed to PRL. These biological functions are mediated by specific membrane receptors. These receptors are non tyrosine kinases, they transduce the signal via associated kinases that are recruited by the receptor and activated upon ligand binding. One of these kinases is JAK2 tyrosine kinase. We have recently shown that another protein - PAK1 - is a novel substrate of JAK2. We showed that JAK2 binds to PAK1 and makes PAK1 more active. Activated PAK1 contributes to better cell survival and cell migration. However, how these two proteins work together and the precise mechanism of their action is unknown. PRL is also involved in breast cancer. Breast cancer is the most commonly diagnosed cancer in women - nearly 1 in 3 (30%) of all cancers in women occur in the breast. Based on the current life expectancy for women in the United States, 1 out of 9 women will develop breast cancer in her lifetime - a risk that was 1 out of 14 in 1960. Much is still unknown regarding the molecular biological mechanism by which a normal cell becomes a cancer cell. Our long term goal is to understand the molecular mechanisms of PRL action and disregulation of which leads to human diseases including breast cancer. Toward this aim, we have started to analyze the relationship between JAK2 and PAK1. In the current proposal we will study how JAK2 and PAK1 increase cell migration and cell survival, and which genes are regulated by these two proteins. Understanding how these proteins work together will help to design new therapeutic approaches and possibly drugs for treatment of different human diseases and breast cancer. __SpecificAimsTextDelimiter__ Specific Aims Prolactin (PRL), a hormone utilized at both the endocrine and autocrine levels, regulates thedifferentiation of secretory glands, including the mammary gland,ovary, prostate, submaxillary and lacrimal glands, pancreas,and liver (for review 76). PRL also regulatesproliferation of different cell types, including mammary epithelium,pancreatic beta cells, astrocytes, anterior pituitary cells,adipocytes, and T lymphocytes (214, 215, 51, 42, 43, 141). Increasing evidence supports the involvement of PRL in breast cancer. The PRL receptor (PRLR) is detected in 80% of human breast cancers (23),and is overexpressed in tumor cells (190). Initiation of PRL signaling involves PRL binding to PRLR and activation of the tyrosine kinase JAK2 which,in turn, phosphorylates the PRLR. Phosphorylated Tyr within the receptor and JAK2 recruit an array of effector and/or signaling proteins. As a consequence of their binding and the accompanying change in their subcellular location, enzymatic activity, and/or phosphorylation state, these recruited proteins initiate pathways leading to the diverse cellular responses to PRL. Thus, JAK2 provides an important link between cytokine receptors and downstream effector proteins. Clearly, JAK2 plays a critical role in PRL action and its dysfunction can have negative consequences in terms of human disease. There is a growing body of research on the proliferative effect of JAK2 in human breast cancer (46-48, 86, 211). p21-activated serine-threonine kinase PAK1 has been implicated in a wide range of biological functions including apoptosis and malignant transformation, cell morphology and motility, gene regulation and stress responses. Recent data suggest that PAK1 is also involved in breast cancer progression. PAK1 is overexpressed or hyperactive in highly proliferative human breast cancer cell lines and tumors (193, 167, 180, 137). Increased PAK1 activity correlates well with increased breast tumor grade (193, 167). Although these observations suggest that PAK1 has a role in breast cancer progression, its precise role in carcinogenesis remains unknown. We have demonstrated that PAK1 is a novel binding partner and a substrate of JAK2 in response to PRL activation. We have identified three tyrosines (Tyr(s) 153, 201 and 285) of PAK1 that are phosphorylated by JAK2. We have shown that tyrosyl phosphorylation of PAK1 by JAK2 protects cells from apoptosis and increases cell motility (162). Our recent data demonstrated that PRL promotes association of JAK2 with the adapter protein SH2B1β, stimulates tyrosyl phosphorylation of SH2B1β and induces cell ruffling in SH2B1β-dependent manner (163). In this grant we propose to examine the hypothesis that prolactin-dependent JAK2 phosphorylation of PAK1 regulates PAK1 activity. Activated PAK1 regulation of target proteins may depend on phosphorylation events or/and protein-protein interactions, leading to the formation of a multiprotein complex that modulates the actin cytoskeleton, increases cell motility and invasiveness, mediates cyclin D1 gene transcription and affects tumorigenecity of human breast cancer cells Specific aims are as follows: Aim 1. To determine the role of JAK2-phosphorylated PAK1 in regulating PRL-dependent actin cytoskeleton rearrangement, cell motility and invasiveness Aim 2. To determine the role of PAK1 in regulating PRL-activated cyclin D1 gene transcription Aim 3. To determine whether JAK2 phosphorylation of PAK1 affects tumorigenicity of breast cancer cells in vivo Although the significance of PRL, JAK2 and PAK1 in breast cancer is widely acknowledged, the mechanisms of their action remain poorly understood. There is a gap between upstream JAK2-dependent events and downstream PAK1 and PAK1-dependent functions in our understanding of the mechanism of breast cancer progression. Our preliminary data suggest that PAK1 is an important signaling molecule phosphorylated by JAK2 and participates in cell motility, invasiveness and cyclin D1 induction. We believe that tyrosyl phosphorylation of PAK1 by JAK2 represents a novel molecular target in the search for the etiology and treatment of human breast cancer. We have begun to communicate with clinical and basic science colleagues interested in breast oncology at the University of Toledo (Dr. Mohamed, Medical Director of the Breast Cancer Center, Medical College of the University of Toledo, see Consulting Letter) and University of Michigan (Dr. Merajver, Scientific Director of Breast Cancer Research Program, University of Michigan, see Consulting Letter). These interactions will facilitate the identification of specimens for further translational research. New